UCLA-UCI Center for Eliminating Cardiometabolic Disparities in Multi-Ethnic Populations (UC END DISPARITIES)

Project Summary/Abstract
P50 UC END-DISPARITIES UC END-DISPARITIES will address the inequitable multilevel factors that
promote cardiometabolic disease, including hypertension, diabetes, atherosclerotic vascular disease and
chronic kidney disease. These conditions are highly influenced by structural disadvantage and
disproportionately affect low-income, minoritized, and other marginalized groups in the highly diverse and
contiguous region of Los Angeles County (LAC) and Orange County (OC). The Center will fill a gap in the
current efforts to advance health equity via a multilevel community-academic partnered approach to
improve cardiometabolic-related health outcomes in targeted LAC and OC Latino, Black, Asian, Pacific
Islander, and American Indian communities, which have some of the highest rates of cardiometabolic risk
factors and premature cardiovascular morbidity and mortality in the nation. UC END-DISPARITIES will
function through three cores and three inaugural center research projects across southern California while
leveraging synergies with key community-academic networks, community health system stakeholders,
regional networks of minority-serving institutions, centers at UCLA and UCI for clinical and translational
science, and methodologic leaders with expertise in health equity research, biostatistics, implementation
science, and health information technology. The Administrative Core, Investigator Development Core, and
Community Engagement Core will implement the following Center objectives: 1) Provide administrative
and operational support for all activities and collaborate with the NIMHD Chronic Disease Disparities
Coordinating Center; 2) Develop the requisite community-academic research infrastructure to improve the
health of the diverse multiethnic communities of LAC and OC through multilevel interventions; 3)
Broaden/enhance existing and new partnerships with communities to expand the pool of diverse
participants in research and recipients of findings for UC END DISPARITIES and related funded entities;
4) Promote successful training and academic advancement of underrepresented post-doctoral and early
career investigators through mentorship, opportunities to participate in community engaged health
interventions, and support of pilot projects and subsequent independent cardiometabolic disparities
research; 5) Conduct rigorous analyses and partner with community stakeholders to identify community,
health system, family, and individual-level correlates of health disparities to inform research methods,
health policy, and the design of community and health system partnered interventions to mitigate
cardiometabolic disparities; and 6) Contribute to the development, evaluation, and dissemination of valid,
reliable, and generalizable tools that can measure and track health outcomes and the social, behavioral,
and economic predictors relevant to multiethnic communities at risk for cardiometabolic disease.

Public health relevance
Project Narrative/Public Health Relevance The “UCLA-UCI Center for Eliminating Cardiometabolic Disparities in Multi-Ethnic Populations” (UC END- DISPARITIES) will address the inequitable multilevel factors, including structural disadvantage, that accelerate the development and progression of cardiometabolic disease and disproportionately affect low- income and minority groups. The center will function across the highly diverse communities that comprise Los Angeles County and Orange County (combined population of over 13 million, more than 46 states). UC END- DISPARITIES will work to prevent cardiometabolic disease, reduce its harmful impact in minority communities, and develop equitable community-partnered research approaches to meet these objectives via three integrated cores, three center research projects, and training programs for new investigators, all working to develop innovative community-relevant approaches to cardiometabolic disease prevention and treatment for southern California's vulnerable communities and at-risk patient populations.